Autophagy activation – a novel strategy for inhibition of human cytomegalovirus

PROJECT SUMMARY/ABSTRACT
Human cytomegalovirus (HCMV) is the most common congenital infection worldwide and a major infectious
complication after solid organ and bone marrow transplantation. A few antiviral agents are used for HCMV
therapy, all target the viral DNA polymerase. Ganciclovir, and its oral formulation valganciclovir are the most
commonly used agents. A terminase inhibitor was recently approved for HCMV prophylaxis after bone marrow
transplantation. Ongoing therapeutic challenges stem from the side effects associated with the DNA
polymerase inhibitors, emergence of resistant virus mutants during prolonged treatment courses, lack of
antiviral combination regimens, and cases of refractory HCMV disease that are non-responsive to all current
antivirals. These serious problems drive the drug development pipeline for HCMV. Identification of novel viral
targets and viral-host interactions will lead to better control of HCMV and will reduce morbidity and mortality
from this pathogen.
Using the LOPAC library of 1280 pharmacologically active compounds, we identified several new hits that
inhibit HCMV replication in vitro at low micro-molar concentrations. Compound ARP101 inhibited several
strains of HCMV, as well as human herpesvirus (HSV) 1 and 2. In addition, ARP101 inhibited a ganciclovir
resistant HCMV, indicating its mechanism of action is different from GCV. Our preliminary data show that
ARP101 induces autophagy, while HCMV mostly aims to inhibit autophagy. Despite autophagy induction, its
substrate p62 is also induced in infected cells treated with ARP101. We therefore hypothesize that the
autophagy substrate p62 is a major hub for HCMV inhibition by ARP101, leading to a non-canonical
autophagy-related pathway that overcomes HCMV replication.
Our goals are: 1) Validate in detail the anti-HCMV activity of ARP101 and define its activity when used in
combination with approved anti-HCMV agents ganciclovir and letermovir; 2) Delineate the autophagic proteins
that are induced by ARP101 for HCMV inhibition, with a specific focus on p62, and 3) Identify the cellular
target(s) of ARP101 using a cell-permeable/bioorthogonal/photolabeling derivative of ARP101, pull down
assays and mass spectrometry.
Success of this project will lead to in-depth target validation studies, which will in turn enable rationale design
of improved derivatives of ARP101 for HCMV inhibition. Our studies will enhance our understanding of the role
of autophagy during HCMV infection and its potential targeting for HCMV therapeutics in combination with
direct acting antiviral agents.

Public health relevance
PROJECT NARRATIVE Human Cytomegalovirus (HCMV) causes serious morbidity and mortality in solid organ and bone marrow transplant recipients and is the most common congenital infection worldwide. The limited treatment options for HCMV are based on inhibition of the viral DNA polymerase; therefore, discovery of new therapeutic strategies against HCMV is urgently needed. The overall aims of this proposal are to identify the mechanism(s) of action and molecular targets of a newly identified HCMV inhibitor, ARP101.